Scripps Center for Oceans and Human HealthAdministrative Core

Administrative Core Summary
The Administrative Core for the Scripps Center for Oceans and Human Health (SCOHH) will be managed out of
Scripps Institution of Oceanography (SIO) at UC San Diego. The Center will be under the leadership of Drs.
Bradley Moore, Skaggs School of Pharmacy and Pharmaceutical Sciences and SIO, and Amro Hamdoun, SIO.
Director Moore will oversee the administrative requirements of SCOHH, provide work direction for center staff,
and ensure that frequent and substantive communication occurs across the research projects and cores, while
Co-Director Hamdoun will assist Dr. Moore and take the lead in integrating the Plan for Enhancing Diverse
Perspectives (PEDP), which will include organizing and managing the new SCOHH summer undergraduate
research intern program to enrich career-enhancing research opportunities for diverse undergraduate
researchers. Drs. Moore and Hamdoun will be supported by an internal steering committee comprised of the
other six project and core leaders. SCOHH will also have an External Advisory Committee (EAC) comprised of
3-5 members with expertise in each research and outreach area along with representation from the community
as well as the health department. The EAC will function to assist in evaluating the impact, synergy, and progress
of the three projects, the Community Engagement Core, and the Administrative Core. We plan to host annual
EAC meetings both in-person (years 1 and 3) and virtually (years 2, 4, and 5), and will schedule the first in-
person EAC meeting to coincide with the COHH4 grantees annual meeting at SIO. The Scripps Center for
Oceans and Human Health will benefit from a dedicated business manager at 50% effort who will be responsible
for the day-to-day functioning of the Center. SCOHH will also be supported by the administrative infrastructure
already in place at SIO, including a business office well versed in NIH/NSF awards, and access to central
departments such as Communications, Government Relations, Foundation Relations, and Innovation and
Commercialization.